Developmental Research Project (DRP) Program

Project Summary – Developmental Research Project (DRP) Program
The Developmental Research Project (DRP) program has been an instrumental part of SC INBRE III’s success
in promoting the growth of biomedical research and increasing student training opportunities in South Carolina
and will continue as a dominant component of SC INBRE IV. As SC INBRE continues to expand its reach
across South Carolina in INBRE IV, our thematic scientific areas match the breath of the institutions and their
faculty in the network. The research areas supported by the DRP program align with the scientific expertise of
the SC INBRE program and include Biochemistry/Cell and Molecular Biology, Bioinformatics, Bioengineering,
Regenerative Medicine and Neuroscience. Independent investigators at the Assistant or Associate Professor
level at participating SC INBRE network or outreach/alumni institutions, who work in or are interested in
developing research projects focusing on any of SC INBRE’s thematic scientific areas, are eligible to
participate. DRP applicants will typically be tenure-track or tenured faculty and may not be the PI on an NIH
R01, R21, R15 or COBRE project. The typical DRP applicant during SC INBRE III was a junior faculty member
in the early stages of their career and that trend is expected to continue in SC INBRE IV. Faculty at more
advanced career stages who wish to re-tool, enter a new area of research, and re-gain competitiveness for
independent NIH funding will also be considered, if they meet the funding criteria noted above. DRP awards
will be for $50,000 for one year and may be renewed up to three years. Six DRPs will be awarded to faculty at
CRUs and eight to faculty at PUIs through a competitive funding process. While all submitted proposal will
undergo review by the Scientific Review Committee and the EAC together, PUI and CRU faculty will not
compete with each other for funding. The review process will be organized by the Administrative Core which
will manage all aspects of the DRP program. The final selection of proposals to be recommended for funding
will be made by the EAC. Each SC INBRE institution has committed to support the success of DRP recipients
with release time, and additional funds in the case of the CRUs, to ensure the awardee can focus his/her
efforts on building their research program and participating in career development activities. Each DRP
recipient will be counseled by their career and scientific advisors and the awardees progress monitored by the
Steering Committee. Upon receipt of an NIH research project grant, a DRP recipient will “graduate” from the
DRP program, but will be encouraged to continue to attend SC INBRE activities and to train SC INBRE
students.